Interspecies Bacterial Signaling to Regulate Salmonella Virulence

PROJECT SUMMARY ABSTRACT
Infections by Salmonella present a constant threat to human health in our country and throughout the world.
Yet, our progress toward controlling salmonellosis has been largely fruitless; antibiotics are rarely warranted,
and, when used, frequently fail due to resistant strains. To control this important foodborne pathogen, it is
essential to understand the means by which it colonizes and induces disease. Chemical signals of the
intestine, including those produced by both the animal host and the microbiota, can repress Salmonella
virulence by reducing its ability to invade the intestinal epithelium. We propose that this signaling defines the
fine balance between virulence and growth of the pathogen. We have found that a novel class of chemicals
produced by species of the Gammaproteobacteria, termed diffusible signal factors (DSFs), potently represses
invasion. DSFs are quorum-sensing molecules that we have found to exist in the large intestine of mice in
sufficient concentration to inhibit Salmonella invasion. They therefore represent both a novel instance of inter-
species signaling and a means by which Salmonella disease and carriage is modulated by its biological
environment. The long-term goal of this work is to identify practical means to inhibit Salmonella invasion in
humans and thus to reduce clinical and sub-clinical salmonellosis. Our objectives are to understand how
invasion-inhibiting compounds function, and to investigate their efficacy in preventing disease. Our central
hypothesis is that the resident microbiota of the large intestine produce chemical signals that repress
Salmonella invasion, and that these signals thus dictate the balance between virulence and growth. We aim to
test the specific hypotheses that: 1) Intestinal chemical signals (including both DSFs and other microbiota-
derived compounds) modulate Salmonella virulence by controlling the proportion of the pathogen population
capable of invasion to dictate disease and carriage; 2) Signaling molecules of varying structures bind within a
single binding pocket of AraC-type invasion regulators, but utilizing different binding moieties, thus dictating
activity and competition among these signals, and; 3) Signals repressive for invasion can be produced in
animals using recombinant bacteria to reduce both clinical signs of salmonellosis and intestinal colonization by
this pathogen. The work described here is significant and innovative as it has potential to identify a novel
means of pathogen control that does not rely upon antibiotics but instead targets attributes essential to
colonization and virulence.

Public health relevance
PROJECT NARRATIVE Salmonella infections present a public health threat in the US and around the world. We aim to investigate the means by which chemical signals of the gut reduce Salmonella virulence and carriage. This research has the potential to identify new and innovative means to reduce or prevent salmonellosis.